Cellular Membrane RNA Activities

This work intends to survey specific RNAs associated with isolated membrane systems of cultured human cells. These RNAs are identified with specific sequences by array hybridization and massed sequencing. Identihed individual membrane-associated RNAs are subsequently screened for binding to purified phospholipid bilayers with the composition of human membranes, in the presence and absence of proteins. Residence on cellular membran es in vivo for RNAs with these biochemical properties is confirmed using FRET between RNA-complementary fluorescent oligonucleotides and membrane dyes introduced into living cells. The intended net effect ofthese three protocols is to detect a subset of membrane-resident RNAs in human cells that have bilayer affinity built into their covalent structures,

Public health relevance
This work seeks to define and elucidate membrane-RNA interactions in which RNA molecules and membrane lipids associate without the intervention of other molecules. Given that this interaction occurs in human cells, previously unrecognized causes of wellbeing and disease will exist in correct or misdirected membrane-RNA interactions. Thus basic biology with biomedical implications is proposed, potentially illuminating a previously unrecognized class of health-related cellular events.